FASEB SRC on The Lung Epithelium in Health and Disease

DESCRIPTION (provided by applicant): The 2014 FASEB Summer Research Conference entitled The Lung Epithelium in Health and Disease will focus on the molecular mechanisms of lung development and disease. This is the 8th biannual conference of developmental and cellular biologists, geneticists, biochemists, physiologists, clinicians and translational researchers with a primary interest in lung epithelial biology, and the only one of its kind. The platform sessions will highlight research on the cellular and genetic basis of lung epithelial lineage specification, differentiation, dysplasia, and lung disease pathogenesis. Each session will be chaired by an expert in the field and will have invited speakers as well as platform speakers chosen from the pool of submitted abstracts. Two sessions will highlight clinical applications of basic science discoveries arising from the investigation of the lung epithelium. There has been a conscious effort to attract established investigators from related disciplines who can complement the expertise of the current pool of investigators focused on lung epithelium. Discussion facilitated by a discussion leader will be an important component of all sessions. Outstanding junior investigators will be awarded travel grants and will be given the opportunity to present their research in platform and poster formats. The three poster sessions will be organized thematically and will be designed to relate to the topics presented in the platform sessions that day. All conference participants dine and socialize together in an informal setting which is conducive to discussion and collaboration. Every effort will be made to include women and underrepresented minorities among the presenters. The goal of this conference is to provide a forum for leading experts to discuss the molecular and cellular basis of lung disease, to present cutting edge research, to integrate concepts and to identify creative and innovative research directions.

Public health relevance
PUBLIC HEALTH RELEVANCE: The 2014 FASEB Summer Research Conference "The Lung Epithelium in Health and Disease" is the primary forum for discussion of pulmonary epithelial science. Cutting edge topics that will be discussed in this 8th iteration of the meeting will include stem cell biology, genomics, state-o-the-art imaging techniques to monitor the lung and clinical application of recent basic science discoveries that can advance the treatment of lung disease. The objective of the meeting is to stimulate meaningful discussion, facilitate collaboration and establish new research directions. The meeting is important to the public health because it is designed to translate cutting edge concepts from bench to beside. (End of Abstract)